Administrative Supplement: Early Career Cancer Clinical Investigator Award (ECIA)

PROJECT SUMMARY/ABSTRACT
Dr. Manali Bhave is an academic medical oncologist with a research focus on early phase therapeutic
clinical trial development involving novel targeted therapies and immunomodulatory strategies for the
treatment of breast cancer. Her goal is to lead institutional investigator-initiated and NCI-sponsored
cooperative group clinical trials that will further advance the fight against cancer. Dr. Bhave plays a
critical role in Winship’s clinical trial program and is extensively involved in NCI-sponsored clinical
trials. She is an active member on multiple national committees including the Breast Cancer Working
Groups for SWOG and ETCTN, and plans to expand her involvement with ECOG-ACRIN and her role
within ETCTN as Emory’s Breast lead. She is the institutional principal investigator of two NCI-
sponsored clinical trials, three investigator-initiated clinical trials at Winship and one investigator-
initiated clinical trial currently under development through SWOG. She also contributes as an active
co-investigator on numerous others. As a phase I and breast oncology leader at Winship, Dr. Bhave
is an important contributor to patient enrollment to NCTN and ETCTN trials. She is Vice Chair of
Winship’s Data & Safety Monitoring Committee, Medical Director of the Phase I Clinical Trials Unit
and Phase I Working Group Lead. In these roles, she has shown tremendous growth as a leader to
broaden the clinical trial portfolio, improve access to phase I clinical trials, and increase faculty
engagement in the Phase I program. Winship Cancer Institute of Emory University fully supports Dr.
Bhave in her career goals to advance as a national leader in clinical trials for breast cancer and early
phase therapeutics, and in her ongoing efforts to enhance the clinical trial program at Winship. The
ECIA award will support protected time for Dr. Bhave to focus on key initiatives to increase trial
accrual at Winship through building a stronger phase I clinical trials infrastructure, and further develop
her own promising protocol concepts at the national level. The ECIA funding mechanism will
undoubtedly help foster academic growth and lead to further leadership roles within Winship and the
NCI Trial Networks.

Public health relevance
PROJECT NARRATIVE Winship Cancer Institute of Emory University fully supports Manali Bhave, MD in her career goals to advance as a national leader in clinical trials for early therapeutics and the treatment of patients with breast cancer, and in her ongoing efforts to enhance the clinical trials program at Winship. The ECIA award will support protected time for Manali to focus on critical initiatives to build her leadership skills both within her institution and at a national level, create process improvements to expand access to and improve accrual to early phase therapeutic clinical trials, and further develop her investigator- initiated clinical trials at the national level. These activities expand upon her current undertakings and include new responsibilities to directly advance her career as an academic clinical researcher and leader at Winship Cancer Institute and within the NCI Trials Network.